Unraveling the Mechanism of Mechanotransduction in Hierarchical Collagen Fiber Formation

PROJECT SUMMARY
Collagen fibers are the primary source of strength and function in tissues throughout the body, particular tendons,
ligaments, and menisci. Cells organize these fibers hierarchically, assemble them from nm-wide fibrils, into larger
fibers and fascicles, growing in size and strength with increasing mechanical demand. Injuries disrupt this
organization, resulting in loss of function, pain, and decreased mobility. Unfortunately, collagen fibers do not
regenerate after injury, nor in engineered replacements, creating a lack of repair options for torn tendons,
ligaments, and menisci. Our long-term goal is to understand how cells regulate collagen fiber formation so to
engineer functional replacements and drive repair in vivo for musculoskeletal tissues throughout the body. As a
step towards this goal, the objective of this proposal is to explore how mechanical cues transmitted via cellular
contraction and stretch-activated ion channels regulate ligament fibroblast’s development of hierarchical fibers.
While cellular contraction forces, highly regulated by integrins, focal adhesion kinase (FAK), and the actomyosin
network, are well established to play a major role in collagen fibril alignment, recent work has suggested stretch-
activated ion channels, TRPV4 and Piezo1, also play independent and transient roles in regulating collagen
organization. However, this work is largely confined to 2D surfaces, unorganized collagen gels, or mouse
models, which all lack the larger fibers and fascicles that dominate human musculoskeletal tissues. Recently, we
developed a novel culture device that guides cells to produce native-size hierarchically organized fibrils, fibers, and
fascicles over 6 weeks of culture. This novel system provides the unique ability to finally dissect the mechanical
cues of development and investigate how these forces guide cells to produce strong hierarchical fibers. We
hypothesize mechanical signals via integrin-based contraction and stretch-activated ion channels are critical to
cell-driven hierarchical fiber formation, with each regulating different aspects of fiber maturation, both with and
without dynamic load. Specifically, we hypothesize that while cellular contraction via FAK is critical to progressive
hierarchical development, TRPV4 will regulate alignment and remodeling at the fibril level, and Piezo1 will
regulate matrix maturation via collagen crosslinking at the fiber and fascicle level. In Aim 1 we will evaluate the
contribution of FAK, TRPV4, and Piezo1 in passive static culture when cell-generated contraction forces drive
fiber formation and in Aim 2 we will evaluate how their contribution changes with dynamic mechanical stimulation.
In both aims, we will investigate how each signaling mechanism, when inhibited or activated, alters collagen
organization at the fibril, fiber, and fascicle length-scale, proteoglycan accumulation, and collagen crosslinking,
all important to overall tissue function and mechanics. A better understanding of how mechanical cues drive cells
to produce hierarchical fibers is integral not only to creating functional replacements, but also identifying
therapeutic targets for regenerating collagen fibers after injury, reducing scar formation, and developing optimal
rehabilitation protocols for regenerating musculoskeletal tissues throughout the body.

Public health relevance
NARRATIVE Aligned collagen fibers are the primarily source of strength in tendons, ligaments, and menisci; however these fibers do not regenerate after injury, nor in engineered replacements, creating a lack of repair options. There is a need to regenerate these collagen fibers to develop functional repairs and replacements for tissues throughout the body. Using a novel culture system, we will investigate how cells sense and response to mechanical cues in developing collagen fibers so to better engineer functional ligament replacements and to drive repair in the body after injury.